Centers for Medicare & Medicaid Services (CMS) Data Linkages

This IAA is related to the exchange of data, whereby NIH/NCI receives Medicare and Medicaid enrollment and utilization (claims and encounter) data for persons in the NIH/NCI Surveillance Epidemiolgy and End Results (SEER) cancer registry who are also found in the CMS data. NIH/NCI then takes the data provided by CMS and merges it with the cancer registry data to create the SEER-CMS datasets: SEER-Medicare, SEER-Medicaid, SEER-Medicare Health Outcomes Survey (SEER-MHOS), and SEER-Consumer Assessment of Healthcare Providers and Systems (SEER-CAHPS). The SEER-CMS datasets are maintained under the NIH/NCI System of Record No. 09-25-0200. Thereby, NIH/NCI oversees the release of data from the SEER-CMS datasets through formal application processes that require requestors to submit research specific study proposals, which must include justification for the requested data and a data storage and protection plan, a NIH/NCI Data Use Agreement, and documentation of an Institutional Review Board assessment. The analyses of the SEER-CMS data allows for insights into cancer care delivery and outcomes across the cancer continuum from screening to end-of-life for a growing proportion of the United States population.

This project is being carried out under interagency agreement entitled “Programming Support to Link SEER Data with Data from the Centers for Medicare and Medicaid Services” between CMS and the National Cancer Institute.

The purpose of the linkage of SEER cancer registry data to CMS data is to facilitate population-based research on the role of cancer screening, treatment and healthcare delivery on health outcomes along the cancer continuum.